Role of SR-mitochondria interplay in calcium-dependent arrhythmias

Project Summary The release of Ca from the sarcoplasmic reticulum (SR) via the ryanodine receptors (RyR2)
regulates the heartbeat. This Ca release process is tightly controlled in healthy hearts but goes awry in diseased
hearts due to genetic or acquired defects of the RyR2 channel complex. These defects typically make the
channel complex hyperactive or leaky, thus giving rise to aberrant Ca release (ACR). While the harmful role of
RyR2-mediated ACR is well-established in a spectrum of cardiac pathologies, much less is known regarding
how ACR is translated into a specific disease phenotype. For instance, ACR is associated with both arrhythmias
and cell death in heart failure and metabolic heart diseases. However, in settings of catecholaminergic
polymorphic ventricular tachycardia (CPVT), a genetic arrhythmia syndrome due to mutations in RyR2 or its
accessory proteins, ACR results in arrhythmias without signs of pathological remodeling. Mitochondria are
involved in myocyte Ca homeostasis to regulate energy production but also cell death. Intriguingly, our recent
study provided evidence that mitochondria behave as an efficient Ca sink in the setting of CPVT, which appears
to be critical to mitigate detrimental consequences of ACR. Interestingly, this protective Ca-absorbing role seems
to be unique to CPVT mitochondria. In contrast, in wild type and several other disease models enhancing
mitochondrial Ca uptake stimulates the emission of reactive oxygen species (ROS) and exacerbates RyR2 leak
and arrhythmias. These studies suggest that mitochondria play a key role in translating ACR into a specific
pathophenotype. They also raised important questions as to why mitochondria in CPVT act as a protective Ca
sink and how that impacts Ca-dependent arrhythmias. Based on data in the literature and our preliminary results,
we hypothesize that protective changes in CPVT mitochondria alter SR-mitochondria interplay to shape diastolic
Ca signal and impact Ca-dependent arrhythmias. Specifically, we propose that in CPVT a dynamic phosphate
(Pi)-based mitochondrial Ca handling mechanism converts mitochondria into a protective Ca sink so they can
absorb ACR; in parallel, tethering (physical contacts) between mitochondria and SR, also known as
mitochondria-associated-membranes (MAMs) are promoted in CPVT to facilitate SR-mitochondria Ca transfer.
Thus, we propose that modulating the Pi-based mitochondrial Ca handling, as well as SR-mitochondria tethering
both impacts arrhythmogenesis. We have designed multiscale studies (from molecule to whole animal) that
employ novel genetic mice models/adeno-associated virus (AAV) 9-mediated gene transfer. We will utilize
methods of cellular physiology, protein biochemistry, and in vivo cardiac functional assays to test our hypothesis.
The proposed studies will help us gain a better understanding of protective molecular changes of CPVT
mitochondria, thus not only benefitting the design of mechanism-based therapies for CPVT, but also providing
clues for the development of therapies for a range of Ca-dependent cardiac dysfunctions that are linked to ACR.

Public health relevance
Project Narrative Cardiac arrhythmias (abnormal heart rhythms) remain a leading cause of death in the United States in part due to abnormal calcium cycling in the heart. This project seeks to gain new insights into how mitochondria impact calcium cycling to contribute to arrhythmogenesis. Information learned from these studies will provide useful guidelines for the development of new therapies for the treatment of heart disorders, especially calcium- dependent arrhythmias.